PB-iCRC: Multi-site Practice-Based Implementation of a ColoRectal Cancer screening intervention

Project Summary/Abstract
Although “implementation intentions”-based tools have been found to enhance colorectal cancer (CRC)
screening uptake, prior studies have not tested to scale their implementation into routine primary care delivery
settings serving hard-to-reach populations such as those with limited English proficiency. Our research group,
led by Prof. KA Greiner, has developed and tested an “I2” CRC decision-making tool via multiple NCI-funded
studies. It addresses the “when,” “where” and “how” details of screening via stool sample tests or colonoscopy.
In this study, we will conduct a parallel cluster-randomized trial in 20 clinics participating in the American
Academy of Family Physicians National Research Network, serving communities in which at least 25% of the
patient population's preferred language is Spanish. Specific aims for the project will be: (Aim 1) To compare
CRC screening outcomes at 6 months between two implementation approaches for our “I2 tool” : (1)
implementation through a Normalization Process Theory-guided Participatory Learning in Action (NPT-PLA
arm) process versus (2) implementation with a usual quality improvement process (control arm) in primary
care practices using a parallel cluster randomized trial; and (Aim 2) to evaluate the facilitators and barriers of
the implementation approach in each study arm using the Normalization Process Theory (NPT) framework.
Multi-disciplinary clinic `implementation teams' that include clinic staff and patients whose preferred language is
Spanish will meet monthly during the first 6 months of clinic participation and aim to integrate the I2 tool into
routine primary care delivery, using the NPT-PLA intervention or control approach. The I2 tool will be delivered
via an on-line RedCap® survey or (if patients prefer) by paper form; and has been customized for use in
English and Spanish. We will enroll all patients in each clinic eligible for CRC screening (a minimum of 100 per
clinic). Primary (Aim 1) outcomes will be CRC screening orders placed (by clinic staff) and completion of CRC
screening (by patients) over 6 months of patient follow-up after initial exposure to the I2 tool. A secondary aim
will be to determine whether completion of the I2 screening tool varies between study arms. For Aim 2, in all
clinics at baseline and after 6 months of clinic participation we will administer a survey based on the NPT
constructs (the “NOMAD”) to assess implementation team members' comprehension of their role in the project,
the salience of our intervention approach, their buy-in, the feasibility of altering workflows, and the potential
sustainability of the intervention in their clinical setting. We will also conduct summative qualitative focus group
discussions in all clinics with the implementation team after 6 months of clinic participation, and at 12 months
with team leaders to assess maintenance. Key personnel include the Multiple-PIs (KA Greiner, J LeMaster, C
Hester), KUMC Biostatistician B Gajewski and an international NPT expert, A MacFarlane. The study will
provide important information on barriers and facilitators of embedding NPT-PLA interventions in “real-world”
primary care clinical settings to promote cancer screening successfully.

Public health relevance
Project Narrative While effective colorectal cancer (CRC) screening interventions have been tested that use state-of-the art technology and behavior change theory, their implementation into routine primary care settings, and how this works best in different contexts, remains to be tested. This parallel cluster randomized study will test at scale an intervention we have piloted successfully: NPT-PLA, an intervention uses an implementation science framework (normalization process theory -NPT) to inform a participatory health research approach: Participatory Learning in Action (PLA) (10 clinics) vs `usual quality improvement (control) (10 clinics). The goal will be to learn which approach works best to integrate into routine primary care delivery a proven decision- making tool (“I2”) that helps patients choose “how” and “when” to screen; and to translate this into CRC screening completion — providing vital information regarding the effectiveness and utility of NPT-PLA in the context of cancer screening.